Dynamics of Altered Metabolic States using a Microfluidic Living Cell Platform

New tools are revolutionizing biomedical research, enabling an exponential growth in the acquisition of data regarding genes, metabolites, proteins, and their structures and functions in normal and diseased states. Among these advances, the ability to monitor profiles of genes on a large scale is notable. However, given the inherent complexity of biological systems, it is difficult to correlate trends with the underlying biological mechanism. In an effort to understand the underlying mechanisms behind metabolic responses to external perturbations, I propose the use of a rigorous systems identification process using microfluidics in which stimuli for different temporal dynamics such as periodic sine waves, step functions, and square waves will be used to probe the underlying biological response. The proposal seeks to develop a new functional genomics approach for studying gene and protein expression: the use of primary cells for the simultaneous temporal expression profiling of multiple genes and proteins and downstream protein capture techniques in a highly parallel, high throughput format. The specific aims are: (1) to determine the activity of transcription factors, which play a key role in the regulation of inflammation and metabolism through transfection of primary rat hepatocytes with dual- reporter plasmid constructs; (2) to simultaneously determine patterns of key molecules secreted by primary hepatocytes in a microfluidic system that has capability to dynamically control the input stimulus; and (3) to determine the effect dynamics of inflammatory cytokine signal transduction has on establishment of different metabolic states such as hypermetabolism and obesity.

Public health relevance
Metabolic diseases constitute burden on US economy and impacts quality of life. The results of this study are expected to directly improve public health by identifying a dynamic link between inflammation and metabolism on transcription and secretome, enabling rational engineering of strategies to mitigate these detrimental effects.